Single-use Microfluidic Device for Radiopharmaceutical Production

ABSTRACT
Radiopharmaceuticals (RPs) are essential linchpins of cancer diagnosis, staging, and therapy. For diagnosis,
the sensitivity and quantitative nature of positron emission tomography (PET) imaging, coupled with the ability
to produce biologically active RPs bearing positron-emitting isotopes, renders PET uniquely capable of detecting
tumors and quantifying their actionable molecular features. Moreover, recent successes in theranostics(1), which
utilize targeted RP pairs for diagnosis and therapy, have led to improved outcomes in challenging clinical
settings, such as neuroendocrine and prostate cancers(2, 3). Encouraged by these results and recent clinical
approvals, pharma and academia alike are investing heavily in RP Research and Development (R&D) in pursuit
of theranostics targeting other solid tumors, such as pancreatic(4, 5), breast(6), and lung cancer(7). Due to the
immense infrastructure, resource, and logistical burdens associated with current strategies for
radiopharmaceutical production (including PET imaging diagnostics and radionuclide therapeutics), the
development and proliferation of radiopharmaceuticals beyond routine diagnostics such as [18F]FDG is
challenging and expensive. The vast infrastructure required to develop, evaluate, and deliver
radiopharmaceuticals, and even radioisotopes themselves, severely limits their deployment to the patients that
need them(8). To address this critical hurdle, we will develop a rapid, inexpensive microfluidics-based approach
for dose-on-demand production of human dosage quantities of ready-to-inject radiopharmaceuticals that can be
adapted to a variety of radiopharmaceutical-related chemistries. In addition to facilitating end-user manufacturing
and purification with a minimum of resources, the proposed platform will simplify raw isotope distribution logistics
by using the chip itself as the shipping container and as the module for purifying (and eventually reacting) the
desired radiometal. The objective of this proposal is to dramatically reduce barriers associated with RP
production, rendering RP discovery and dissemination dramatically more accessible. To achieve these
goals, we will build upon our prior development of the radiometal sub-family of simple, inexpensive, microfluidic
‘single dose-single device’ radiosynthesis platform RAPID-M (Radiopharmaceuticals As Precision Imaging
Diagnostics-Metals). Based upon our published and preliminary studies, our Specific Aims are: To employ
RAPID-M as a “ship-on-chip” device for simple isotope purification, transport and downstream, end-user
application (Aim 1); to demonstrate RAPID-based synthesis of a theranostic pair for imaging and therapy (Aim
2); and to automate the RAPID concept to allow for production of RPs with minimal operator intervention (Aim
3).

Public health relevance
PROJECT NARRATIVE The immense infrastructure, resource, and logistical burdens associated with current radiopharmaceutical production and distribution limit the proliferation and development of these valuable drugs with crucial diagnostic and therapeutic capabilities. To address this critical hurdle, we will develop a rapid, inexpensive microfluidics-based approach for low-cost, dose-on-demand production of human dosage quantities of ready-to-inject radiopharmaceuticals that can be adapted to a variety of relevant chemistries. Further, we will develop the proposed platform as a means to simplify raw isotope distribution logistics by using the chip itself as both the container for shipping and the module for purifying (and eventually reacting) the desired radiometal.